Algorithm to Identify Patients at Risk of Medication-Related Hospitalization

The long-range goal of this fast-track research application is to improve healthcare quality and reduce
healthcare costs nationwide among those at risk for medication-related hospitalization. The specific objective
of this proposed research is to develop an algorithm that uses existing electronic health information to
efficiently identify patients at risk of medication-related hospitalization so that they can be referred for
medication management services. The project will design, program, and test an algorithm to accurately
identify patients at risk of medication-related hospitalization. The algorithm will be tested against a pharmacist
review of cases to confirm that the algorithm accurately identified patients at risk of medication-related
hospitalization using evidence-based criteria and based on a Receiver Operating Characteristic (ROC) curve
analysis. The algorithm will also be tested in terms of user acceptance. For each user group, the algorithm will
be deployed, and the user's satisfaction with and use of the information provided about each patient will be
assessed.

Public health relevance
This project will advance the ability of healthcare providers to avoid medication problems in high risk patients, most of whom are older adults. It will also contribute to the sustainability of the healthcare system by improving efficiency and reducing medication-related hospitalizations.